IGF::OT::IGF Development & Manufacture of Pharmaceutical Products for the Treatment of Substance Abuse Disorcer. NIDA Ref. No. N01DA-16-8926; POP: 09/18/2016 - 09/17/2021.

The purpose of this contract is to carry out the development and manufacture of pharmaceutical preparations to be used in the medications development program for addiction treatment at the National Institute on Drug Abuse (NIDA).